Understanding the impact of targeting the epigenetic regulation of lung stem cells in congenital lung disease

Project Summary
Congenital lung diseases are serious disorders which prematurely end the lives of many and place large health
burdens on surviving individuals throughout their lives. Congenital Diaphragmatic Hernia (CDH) is one such
disease which causes severe underdevelopment (hypoplasia) of the lung. Although the hernia can be
surgically repaired, the lung defects are persistent, leading to high mortality and complicated long-term care for
survivors. There are many genetic factors contributing to CDH, and some of these genes change lung
development independently from the effects of the hernia, showing their intrinsic importance to the normal
growth of the lung. Through a synthesis of genomic and transcriptomic analyses of CDH patients we have
identified two genes, KMT2D and KDM6A as strong candidates to mediate the severe lung hypoplasia. KMT2D
(Lysine Methyltransferase 2D) and KDM6A (Lysine Demethylase 6A) are co-operating epigenetic regulators
which can be both mutated and downregulated in CDH and are known to be important to stem cells. New
technological advances have allowed us to isolate lung epithelial basal stem cells from the tracheal aspirates
of recruited CDH and control patients. We will utilize these cells to test if the loss of function of these epigenetic
regulators affects the ability of these cells to self-renew and generate differentiated lung epithelium, and to
identify the downstream genes which they control. Our specific aims are 1) Determine the effects of pathogenic
KMT2D/KDM6A genetic variants and pharmaceutical interventions on the differentiation/self-renewal of patient-
derived lung basal stem cells derived from tracheal aspirates, and 2) Map the H3K4me1 and H3K27me3
epigenetic changes in CDH and control basal stem cells following mutation or inhibition of KMT2D/KDM6A.
With this approach we will be taking advantage of the genetic breakthroughs in CDH to make discoveries that
are potentially relevant to a whole class of lung diseases. These aims will help us understand how the
mechanisms governing lung development go awry and enable us to develop therapies to correct these
problems.

Public health relevance
Project Narrative Congenital Diaphragmatic Hernia (CDH) is a serious disease resulting in underdeveloped, hypoplastic lungs which are among the leading causes of death of newborn infants. This proposal will investigate how the epigenetic regulation of lung stem cells contributes to this lung hypoplasia, by disrupting key epigenetic regulator genes in lung stem cells from control and CDH patients. Through understanding why these genes are needed by lung stem cells and what they do, we can go on to design and test new treatments that will stimulate the stem cells of underdeveloped lungs to grow and mature them.